Composition, sorting, and morphology of the apical plasma membrane in epithelial cells.

Project Summary
Epithelial cell polarization is an essential biological process, serving many physiological roles including tissue
morphogenesis and wound healing. A defining feature of polarization is the separation of cell plasma membrane
(PM) lipids and proteins into apical and basolateral compartments between which molecular exchange is
restricted. Decades ago, the apical PM was found to be enriched in saturated lipids, glycolipids, and cholesterol.
Mechanistic hypotheses to explain the biogenesis and unique composition of the apical PM include self-
assembling membrane domains (i.e., lipid rafts), specific protein sorting motifs, and post-translational
modifications mediating protein sorting. However, neither the detailed composition nor the mechanisms of protein
and lipid sorting between PM domains in epithelial cells have been resolved. The lipid profile of the basolateral
PM remains unresolved, leaving doubts about the differentiation and lipid separation of the apical and basolateral
PM. The general determinants of protein sorting are poorly understood, with past studies focusing on either
specific proteins or trafficking machinery. Importantly, the apical PM hosts an extensive extracellular glycocalyx
consisting of glycolipids, glycoproteins, and polysaccharides, which can be crosslinked by sugar binding proteins
called lectins natively present in the extracellular space. The role of these glycocalyx molecules on protein sorting
has not been revealed, despite a major fraction of apical proteins being glycosylated. Finally, the apical PM of
polarized epithelia takes on highly outward-curved membrane shapes such as cilia or microvilli, but must also
be simultaneously capable of forming inward membrane invaginations for cell signaling and uptake from the
extracellular space. The driving forces for the formation of these highly-curved membrane structures remain
undetermined. We will investigate these knowledge gaps in membrane and epithelial biology. In Aim 1, we will
use advanced lipidomics and imaging techniques to characterize the changes in lipid organization, membrane
composition, and membrane properties during the cellular polarization process. We hypothesize that the apical
PM will be enriched in highly saturated lipids and glycolipids relative to the basolateral PM, with apical PM
biophysical properties reflecting a raft-enriched environment. In Aim 2, we will systematically evaluate the
transmembrane protein structural determinants of apical versus basolateral sorting including transmembrane
domain features, protein raft affinity, and glycosylation. We hypothesize that these protein features cooperatively
direct protein sorting to the apical PM. In Aim 3, we will explore the role of the apical PM glycocalyx in driving
membrane bending. We hypothesize that lectin-mediated interactions control the curvature and organization of
membranes. Successful execution of these aims will address several largely open questions in membrane
biology about how lipid composition, membrane properties, and protein structural features coordinate to organize
composition and structure of the polarized cell PM.

Public health relevance
Project Narrative Epithelial polarization – an essential biological process serving many physiological roles including tissue morphogenesis and wound healing – relies on the separation of the cell plasma membrane into distinct apical and basolateral domains with unique lipid and membrane-protein constituents. Despite the critical nature of polarization, the fundamental determinants of the composition, structure, and function of apical and basolateral membrane domains remain unknown. I will examine the lipid components of the membrane and the consequent biophysical membrane properties, investigate the structural determinants of polarized protein sorting, and explore the role of apical plasma membrane elements on determining membrane structure, namely the formation of epithelial tubules such as cilia or microvilli.